Stimulating Lymphocyte Activation Combined with Inhibition of Immunosuppressive Signals in Colon Cancer Metastases

Project Summary/Abstract
Colon cancer and colorectal liver metastases (CRLM) are a significant and increasingly lethal disease. Though
there is a strong scientific premise to harness the immune system to treat this cancer, there remains a funda-
mental gap in understanding of how immunotherapies can be utilized for the majority of these tumors, particu-
larly microsatellite stable cancers. The central hypothesis is that the tumor microenvironment can be manipu-
lated to enhance cytotoxic lymphocyte infiltration and activation, and that checkpoint blockade can be simulta-
neously utilized to incite a clinically relevant immune response. This “one-two punch” hypothesis has been
formulated on the basis of preliminary data produced by the applicant where increased T-cell trafficking to tu-
mors, when combined with CTLA4 blockade, resulted in complete CRLM regressions. The rationale for the
proposed research is that once it is known how to enhance immunostimulatory signals in the microenvironment
and simultaneously suppress inhibitory influences, a new strategy for the management of colon cancer is pos-
sible. Supported by a very strong scientific premise based on published papers and robust preliminary data,
this hypothesis will be tested by pursuing three specific aims: 1) Determine mechanisms to enhance lympho-
cyte proliferation and anti-tumor specific immune responses in colon cancer by manipulating immunosuppres-
sive signals, 2) Examine mechanisms that supply immunostimulatory influences directly into the tumor; and 3)
Combine checkpoint blockade with selective delivery of human LIGHT to treat surgically resected tumors and
human CRLM in a pre-clinical autologous system. Under the first aim we expect to increase lymphocyte infiltra-
tion, proliferation and activation while simultaneously curbing immunosuppressive signals/cells in the microen-
vironment utilizing a validated pre-clinical model established by the applicants. In the second aim, a clinically
relevant method to safely increase LIGHT expression within colon cancer tumors using novel tumor-specific
viral delivery mechanisms engineered by the applicants will be analyzed. Under the third aim, patient tumors
will be utilized in an autologous humanized mouse model and treated with CTLA4 blockade combined with on-
colytic viral delivery mechanisms to increase LIGHT expression. The proposed research is innovative, because
the multi-combination therapy of LIGHT expression in CRLM with tumor-specific oncolysis and checkpoint
blockade will deliver an inventive approach that will be universally applicable from patient to patient. New hori-
zons that will stem from this innovative strategy include a better understanding of anti-CTLA4 biology that may
not only enhance response rates, but also vastly increase indications for its use in previously “cold” tumors,
including microsatellite stable gastrointestinal cancer. This contribution will be significant because it will estab-
lish a synergistic combination of immunotherapies that will have direct translational impact on one of the dead-
liest cancers worldwide. The implications of our results may improve patient quality of life and provide survival
advantages over the best current surgical and chemotherapeutic strategies for this disease.

Public health relevance
Project Narrative Over the last decade, colon cancer and CRLM have increased in young U.S. men and women resulting in a 1% annual increase in mortality. The proposed research is relevant to public health because the discovery of strategies to optimize anti-tumor immune responses in this dis- ease is ultimately expected to improve patient outcomes compared to the best current thera- pies. Despite the exciting results of immunotherapy and checkpoint blockade in many previously therapy-resistant malignancies, the field is currently stymied in how to utilize this technology to battle microsatellite stable (>95%) colon cancer, and, as a result, the proposed research is rele- vant to the NIH's mission to develop improved immunotherapy approaches of novel combina- tions to define how immunosuppressive tumor promoting environments can be overcome.